Function, regulation, and conservation of hypoxia-induced glycolysis condensates

PROJECT SUMMARY
In low oxygen conditions, such as the hypoxic microenvironment of solid tumors, cells cannot perform
mitochondrial respiration and rely solely on glycolysis for ATP generation. Thus, to overcome this deficit in energy
production, cells require mechanisms to enhance ATP generation in response to hypoxia. We discovered that in
hypoxic yeast cells, the enzymes of the glycolysis pathway, which are diffusely localized in the cytosol under
normoxic conditions, organize into non-membrane-bound structures we term Glycolytic (G) bodies. G bodies
constitute ribonucleoprotein (RNP) condensates formed by phase separation. G body formation is correlated
with increased glucose consumption and cell survival and proliferation under hypoxia. Similar structures have
been observed in C. elegans and human cancer cell lines, supporting G body formation as an evolutionarily
conserved adaptive response. We hypothesize that G bodies enhance rates of glycolysis by coordinating the
multiple steps of the pathway to promote cell survival during hypoxic stress conditions. Using biochemical
purification, we have determined the protein and RNA constituents of G bodies and our genome-wide deletion
screen identified key signaling pathways that influence G body formation. A major gap in the condensate field is
the lack of direct evidence for condensate function. Our preliminary results indicate that G bodies exhibit
enhanced glycolytic enzyme activity, thus supporting a functional role for these novel RNP condensates. In this
proposal, we will employ a diverse array of experimental strategies to investigate G body activity, physiological
impact, biogenesis, biophysical properties, and functional conservation. Mechanisms by which G bodies
potentiate glycolytic enzyme activity will be pursued using our purified G body in vitro system and by utilizing
novel metabolic biosensors in vivo. We will also determine the global metabolic impact of G bodies through
metabolomic approaches and investigate the genetic regulation of G body biogenesis and function mediated by
conserved energy-sensing signaling pathways. Molecular and biophysical analysis of G bodies will examine the
role of non-canonical RNA binding by glycolysis enzymes in condensate formation via phase separation. Finally,
we will take the lessons learned in yeast and apply them to human cancer cell lines and 3D spheroid cultures to
study the conservation of G body biophysical properties, biogenesis, and physiological function. Successful
outcomes of our research will reveal novel basic principles of RNP condensate regulation and function across
species and provide mechanistic insights and potential therapeutic strategies to mitigate hypoxic adaption and
cell proliferation in solid tumor microenvironments.

Public health relevance
PROJECT NARRATIVE Hypoxia induces glycolysis enzymes to coalesce into RNP condensates, termed Glycolytic bodies (G bodies), whose formation correlates with increases of glucose flux and cell proliferation in yeast. Using a wide array approaches, we will test the function, structure, and regulation of G body formation in yeast and mammalian systems. This work will reveal mechanisms of condensate function and principles of cell adaptation to hypoxia, providing insights into how cancer cells proliferate in hypoxic tumor microenvironments.